Quantitative molecular MR-PET imaging of glycolysis in glioblastoma

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM) is a uniformly fatal disease with very few clinical options. Recent work from our lab and
others indicates that abnormal signal transduction, originating from oncogenic drivers and loss of tumor
suppressors, results in heightened glycolytic flux in GBM. Correspondingly, inhibition of oncogenic signaling or
downstream signal transduction pathways using targeted therapies can induce rapid and specific alterations in
glycolysis, resulting in reduced tumor energetic and biosynthetic capacity, making the tumor vulnerable to further
therapeutic exploitation. Such an imaging biomarker would be useful for providing unique insight into glucose
metabolism and behavior, allowing clinicians to identify and ultimately exploit potential therapeutic vulnerabilities.
While 18F-fluorodeoxyglucose (18F-FDG) PET imaging is an obvious candidate biomarker for imaging glycolysis
as it is used ubiquitously in other cancers to monitor tumor metabolic behavior and treatment response, 18F-FDG
PET uptake is a measure of overall glucose utilization, not specifically glycolysis. To overcome this ambiguity
and provide more specificity for glycolysis, we propose combining standard of care 18F-FDG PET with fast pH
and oxygen-sensitive amine chemical exchange saturation transfer spin-and-gradient-echo echoplanar imaging
(CEST-SAGE-EPI), a molecular MRI technique that can estimate both acidity from lactic acid and oxygen
utilization, as well as perfusion and diffusion MRI to account for the effects of blood flow/volume and cell density.
We hypothesize combining 18F-FDG PET, amine CEST-SAGE-EPI, perfusion MRI, and diffusion MRI to create
a “glycolytic index”, or GI, will allow us to accurately quantify glycolytic flux within heterogeneous tumors on
widely available clinical imaging systems for use in studying glucose metabolism and response to a variety of
targeted therapies in human GBM.
The current study will investigate the central hypotheses that: (Aim 1) biopsied tumor tissue undergoing high
levels of glycolysis via RNA expression, protein expression, and bioenergetics analyses can be reliably detected,
correlates with direct measure of tissue pH, and strongly associated with a “glycolytic index” created by
combining 18F-FDG PET, amine CEST-SAGE-EPI, perfusion MRI and diffusion MRI; and (Aim 2) changes in
this “glycolytic index” can be detected by perturbing glucose metabolism using a brain penetrant EGFR inhibitor
specifically designed for GBM and correlate with pharmacologic alterations and alterations in glycolytic signaling
in patients with IDH wild-type, EGFR amplified GBM.

Public health relevance
NARRATIVE Glioblastoma (GBM) is a uniformly fatal disease with very few clinical options and is driven by abnormal signal transduction, originating from oncogenic drivers and loss of tumor suppressors, resulting in heightened glycolytic flux that can be therapeutically targeted for exploitation. We hypothesize a combination of standard of care 18F- FDG PET, which measures glucose uptake, fast pH- and oxygen-sensitive amine chemical exchange saturation transfer spin-and-gradient-echo echoplanar imaging (CEST-SAGE-EPI), a molecular MRI technique that can estimate acidity from lactic acid and oxygen utilization, as well as perfusion and diffusion MRI to account for the effects of blood flow/volume and cell density can be used to create a “glycolytic index”, or GI, that will allow us to accurately quantify glycolytic flux within heterogeneous tumors on widely available clinical imaging systems for use in studying glucose metabolism and response to a variety of targeted therapies in human GBM. The current study will (Aim 1) confirm the association between tumor tissue measures of glycolysis and the “glycolytic index”; and (Aim 2) quantifying changes in the “glycolytic index” and correlation with glycolytic signaling alterations through perturbation of glycolysis using a brain penetrant EGFR inhibitor specifically designed for GBM (i.e. ERAS801).